An intersectional examination of early tobacco use among White and Black adolescents

PROJECT SUMMARY
Tobacco use is a prominent cause of preventable health disparities between White and Black individuals.
Tobacco use is primarily established in adolescence. Although the lifetime prevalence of tobacco use is lower
for Black than it is for White individuals, Black adolescents are less likely to quit tobacco once they initiate use.
In the long run, Black individuals suffer disproportionately from tobacco-related death and disease. Significant
progress has been made in identifying risk and protective factors for tobacco use in the general population.
These factors are commonly addressed in standard tobacco control strategies. However, relative to Whites,
Black individuals face diminished gains from standard tobacco control strategies. Our central hypothesis is that
said diminished gains are explained by complex and dynamic interrelations between multi-level risk and
protective factors for tobacco use that vary between White and Black adolescents. Current approaches for
understanding tobacco use do not investigate these interrelations, which is a critical barrier for the
development of targeted interventions that effectively mitigate tobacco use among Black adolescents. In this
proposal we will employ a theoretically grounded and innovative conceptual model to examine Black-White
differences in tobacco use across multiple intersecting domains and levels of influence. We will use adolescent
data collected as part of the PATH study, the largest nationally representative longitudinal cohort study of
tobacco product use in the US. Our aims include cross-sectional as well as longitudinal examinations across
the four waves of PATH data. First, we will identify differences in the combination of risk and protective factors
between Black and White adolescents. These analyses will explicate how unique risk factors among Black
adolescents explain cross-sectional Black-White differences in tobacco use onset, types of products used, and
frequency of use. Second, we will examine differences in the progression of risk and protective factors over
time between White and Black adolescents. These analyses will elucidate unique patterns of risk and
protective factors over time and their relation to tobacco use in the long run. This study’s findings will advance
our understanding of diminished gains for Black individuals from standard tobacco control approaches. Further,
this developmental study will identify new potential therapeutic targets for clinical and public health intervention
development. Thus, findings from this project will have a sustained and powerful impact on the field of tobacco-
related health disparities research.

Public health relevance
PROJECT NARRATIVE This project promises to inform public health research by identifying concomitant multi-level factors that uniquely influence tobacco use among Black adolescents. This work will advance our understanding of diminished gains for Black individuals from standard tobacco control approaches. The results will identify new potential therapeutic targets for clinical and public health intervention development.